Light scattering device for the development of protein clouds

Project Summary
The supplement fund is requested under PA-20-272, NOT-OD-24-048, and NOT-GM-24-021 to purchase a
light scattering device, which will support NIGMS R01GM152704-01. The proposed research in R01GM152704
develops a new gene and drug delivery approach by activating biogenic nanoparticle complex, also known as
protein clouds, using ultrasound remotely to deliver Cas9-ribonucleoproteins safely and efficiently. After we
isolate and synthesize gas vesicles (GV) and protein clouds for delivery, we will measure hydrodynamic radius
and z-potential of protein clouds and individual GVs to confirm their size and tendency to aggregation. We
require reliable light scattering device, capable of determining the size of particles using dynamic light
scattering (DLS) and understanding sample stability using electrophoretic light scattering (ELS). The requested
state-of-the-art and single laboratory light scattering device will allow us to facilitate the successful
development of the proposed approach.

Public health relevance
Project Narrative The supplement fund is requested under PA-20-272, NOT-OD-24-048, and NOT-GM-24-021 to purchase a light scattering device for the NIGMS R01 funded research. The device will accelerate the development of the next generation intracellular delivery platform for cell engineering. The proposed approach has the potential to provide advanced genetic modifications that are required to treat advanced diseases such as solid tumor immunotherapy and neurodegenerative diseases.